Elucidating the within- and between-host adaptations driving S. aureus persistence within the bladder of long-term catheterized individuals

PROJECT SUMMARY/ ABSTRACT
Urinary catheterization is among the most common medical procedures in the US. Up to 22% of long-term care
residents and 60% of critically ill patients receive a urinary catheter (UC) due to its efficacy at improving patient
quality of life (QOL). However, urinary catheterization increases the risk (7% per day) of developing
asymptomatic bacteriuria (ASB) and virtually all long-term UCs (>30 days) become colonized. ASB increases
the risk of developing symptomatic catheter associated urinary tract infections (CAUTIs), which are currently the
most common hospital-associated infection in the US and account for 1 million cases annually. In contrast to
urinary tract infections (UTIs) in healthy individuals, CAUTIs and ASB are caused by a wide range of
uropathogens that are often multidrug resistant (MDR), which complicates empiric treatment. For individuals with
long-term UCs, ASB can serve as a reservoir, as these MDR uropathogens can persist for weeks despite
antimicrobial treatment and UC changes. Problematically, the urinary tract is the most common source of
secondary bacteremia in the hospital, as the bladder provides a direct route for these MDR pathogens to the
bloodstream. Despite the wide range of CAUTI and ASB uropathogens, most studies still focus on the most
common UTI pathogen, Escherichia coli, and other Gram-negative bacteria. Importantly, recent studies
emphasize the importance of Gram-positive bacteria in CAUTI and ASB. Staphylococcus aureus is of particular
concern as it i) is one of the most frequent causes of ASB, i) is typically methicillin resistant (MRSA), is found
causing severe disease more often than other uropathogens, and iii) can block long-term UCs via urease
produced crystal formation, which increases the frequency of UC changes needed, thereby decreasing QOL. As
the US population continues to age, long-term UCs and subsequently MRSA CAUTI will become more common,
highlighting the need for studies in this area. Surprisingly, few studies have investigated MRSA during CAUTI
and no study has investigated how MRSA adapts during long-term ASB or how that adaptation affects
pathogenicity. My genomic analyses of serial S. aureus strains from individuals with long-term UCs demonstrate
that only a handful of genomic changes occur within strains that persist for months. Further analyses of mutations
within a subset of these isolates demonstrate several genes (involved in metabolism, antibiotic resistance, and
virulence) are under selection. Consistent with these findings, urease activity among serial S. aureus UC-
associated strains increases over time. Thus, I hypothesize that as S. aureus persists within the catheterized
bladder, genomic changes within antibiotic resistance and virulence genes promote pathogenicity and
persistence. I will utilize our collection of S. aureus isolates to test this hypothesis through the following aims: i)
identify the within- and between-host genomic adaptions driving persistence in long-term UCs and ii) assess the
impact of genomic adaptions on pathogenicity and persistence. The completion of this proposal will identify
genomic adaptations that may be used as biomarkers to better manage MRSA CAUTI.

Public health relevance
PROJECT NARRATIVE Urinary catheterization, the most common medical procedure in the US, increases the risk of developing i) asymptomatic bacteriuria (ASB), which can act as a reservoir for multidrug resistant uropathogens and ii) symptomatic catheter associated urinary tract infections (CAUTIs), which can progress to more severe diseases such as bacteremia and sepsis. Notably, ASB and CAUTI are often caused by understudied uropathogens, with the gram-positive bacterium Staphylococcus aureus being one of the most frequent persistent colonizers in individuals with long-term urinary catheters. This proposal leverages longitudinally collected S. aureus isolates from individuals with long-term urinary catheters to identify the within- and between-host adaptions under selection in the catheterized bladder and investigate how these adaptations influence CAUTIs outcomes, which will provide the results needed for a future R01 proposal.